How the endocytic network mediates specificity of cell signaling

Abstract: How the endocytic network mediates specificity of cell signaling
Receptor crosstalk – the cooperation between two or more receptors to modulate cell responses – is a key
signaling mechanism. It enables cells to generate a large combinatorial repertoire of specific signaling with a
limited variety of receptors. Receptor crosstalk plays an essential role in cell physiology. Consequently,
dysfunctions in receptor crosstalk are associated with many human diseases, such as infectious diseases
(including COVID-19), cancer, and cardiovascular diseases. To understand the physical mechanisms by which
signals from different receptors are integrated in crosstalk, studies have exclusively focused on receptor
interactions at the plasma membrane. In contrast, how the crosstalk signals are transduced with high fidelity
from the plasma membrane to the nucleus is poorly understood and scarcely explored.
The overall goal of this research is to establish the functional role of the endocytic network in transducing and
regulating receptor crosstalk. Under the prior ESI-R35 support, our group has made pioneering discoveries
in support of the central hypothesis that the endocytic network is where extracellular chemical and
physical stimuli intertwine to regulate receptor crosstalk. Specifically, we reported a new model in which
receptors can crosstalk by forming overlapping interfaces between discrete signaling clusters, challenging the
prevailing view that receptors oligomerize to crosstalk. Importantly, such spatially organized interaction between
receptors at endosomes and plasma membranes is modulated by extracellular physical cues, and directly
regulates cell inflammatory responses. These prior discoveries and the plethora of new approaches we
developed for studying endosome functions laid a critical and unique foundation for us to address the
knowledge gap: how does the endocytic network mediate receptor crosstalk? We will address how the
endocytic network orchestrates chemical cues from receptor crosstalk (Direction 1), and transduces
extracellular physical cues to refine the specificity of crosstalk signaling (Direction 2). To address the first
direction, we will define the physical mechanisms by which endocytic sorting, collective endosome-organelle
interactions, and endosome-specific activation modulate crosstalk signaling originated from the plasma
membrane. To address the second direction, we will integrate experiments with computational modeling to
determine the feedback loop between the endocytic network and cell-matrix interactions that regulate receptor
crosstalk. This project will establish a mechanistic and predictive understanding of how the endocytic network
mediates the spatiotemporal specificity of receptor crosstalk and cell signaling in general; a topic that is poorly
understood. It will also lower the technical barrier that has impeded research on this topic, by establishing novel
quantitative toolsets for dissecting the dynamics and function of the endocytic network on multiple length scales.
Ultimately, a better understanding of endosome functions in receptor crosstalk will facilitate the development of
new therapeutic strategies for diseases, such as immune adjuvants for cancer therapies and vaccines.

Public health relevance
Project Narrative The proposed research is relevant to public health because receptor crosstalk underlies the pathogenesis of many human diseases from autoimmune diseases to cancer, and because endocytosis is a vital cellular process. Understanding the functional role of endocytosis in receptor crosstalk will facilitate the development of new therapeutic approaches, such as immune adjuvants for cancer therapies and vaccines. Thus, the proposed research is relevant to the part of NIH’s mission that seeks to increase fundamental knowledge of biological processes that will lay the foundation for advances in disease diagnosis, treatment, and prevention.